Investigating the effects of increasing O-GlcNAcylation in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease is a devastating neurodegenerative disease with limited therapeutic options. Progressive
accumulation of the pathological markers, hyperphosphorylated Tau (pTau), amyloid-beta, and gliosis begin up
to 20 years before cognitive impairment occurs. Published reports from our lab and others have shown that the
TgF344-AD rat model displays many of the early pathological abnormalities that occur in patients with AD,
including endogenous pTau accumulation in the locus coeruleus prior to other brain regions, Aβ accumulation
throughout hippocampus, degeneration of noradrenergic (NA) axons in hippocampus, reactive astrocytes and
microglia, as well as a synaptic dysfunction as early as 6 months in the dentate gyrus. Therapeutic strategies
that interfere with these pathological changes could slow disease progression. Increasing the post-
translational modification, O-GlcNAcylation, has received recent attention, as it competes with serine/threonine
phosphorylation on Tau, preventing its hyperphosphorylation and accumulation. Increasing O-GlcNAcylation
also increases non-amyloidogenic processing of amyloid precursor protein due to O-GlcNAcylation of gamma
secretase. Pharmacological inhibitors of O-GlcNAcase, the enzyme that removes O-GlcNAc moieties from
proteins, are currently in clinical trials for the treatment of AD in patients. Using the TgF344-AD rat model and a
combination of technical approaches including immunohistochemistry, confocal imaging, Western blot and
brain slice electrophysiology, my dissertation research focuses on pharmacologically increasing O-
GlcNAcylation in TgF344-AD rats to test whether it is therapeutically beneficial by (1) decreasing pathogenic
accumulation of pTau and amyloid-β (Aβ), preventing NA axon degeneration, and decreasing astrocyte and
microglia activation, (2) prevents the pathologically increased LTP due to β-ARs function at MPP-DG synapses
and (3) maintaining astrocyte function, including astrocytic β-ARs.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease is a devastating, progressive neurodegenerative disease with few therapeutic options available to delay memory impairment. The post-translational modification, O-GlcNAcylation, is a promising therapeutic strategy since it can decrease accumulation of the pathological hallmarks, phosphorylated Tau tangles and amyloid-beta plaques. Using a transgenic rat model of Alzheimer’s disease, I will investigate whether increasing O-GlcNAcylation can protect against damage to the noradrenergic system and reduce hippocampal gliosis and synaptic function in early stage of the disease.